TGF-ß-SOX18-Collagen metabolism in pulmonary vascular disease associated with CHD

ABSTRACT
Children born with common congenital heart defects that cause increased pulmonary blood flow (PBF) develop
abnormal pulmonary vascular reactivity and, if untreated, pulmonary hypertension (PH). Vascular morphology
studies in lambs born with surgically created left-to-right shunts (Shunt) demonstrate a >2-fold increase in
pulmonary arterioles and increased proximal pulmonary artery (PA) stiffness. While this increase in
angiogenesis represents an early adaptation to increased PBF and is not typically observed in adults with late-
stage disease, proximal PA stiffness is common to all PH and is a driver of disease pathogenesis. While a
hyperproliferative, anti-apoptotic endothelial phenotype is necessary for angiogenesis, the primary drivers of
MPA stiffness in PH are ill-defined. Metabolic rewiring is a unifying endothelial feature in PH. Pulmonary arterial
endothelial cells (PAEC) isolated from Shunt lambs exhibit significant metabolic rewiring to favor a Warburg
phenotype that supports the biosynthetic demands of angiogenesis. However, the inciting pathways have yet
to be elucidated, and how they contribute to vascular remodeling remains unknown. We have further
demonstrated that the endothelial-specific SOXF family transcription factor (TF), SOX18, is upregulated in
Shunt lambs. SOX18 induces an angiogenic response in the lung, and the SOXF family can regulate PAEC
metabolism. Thus, SOX18 signaling is an attractive therapeutic target, although transcription factors are
typically difficult to drug. Our novel hypothesis is that SOX18 induction triggers an early metabolic adaptation,
resulting in aerobic glycolysis and increased proline biosynthesis necessary for the angiogenic EC phenotype
and the collagen production required for MPA stiffness. We also hypothesize that upstream TGF-β signaling
is responsible for the induction of SOX18 in Shunt lambs and that SOX18 directly represses Phd2 gene
expression to drive HIF-2-mediated proline biosynthesis and the disruption of fatty acid oxidation (FAO) via
PPARγ inhibition. This hypothesis will be evaluated in three interrelated but independent Specific Aims (SAs).
SA#1 will define the role of the TGF-β-SOX18-Proline axis in developing the angiogenic phenotype and
collagen production associated with increased PBF. SA #2 will define the novel role of SOX18 in HIF-2α-
mediated metabolic reprogramming in shunt PAEC. SA #3 will evaluate the therapeutic potential of directly
inhibiting SOX18 activity or collagen production via novel approaches. We will use two intervention strategies.
First, a prevention model in which therapy is delivered chronically for 4 weeks starting immediately after birth;
second, a reversal study in which therapy is delivered in a novel post-shunt closure model mimicking
surgical correction of the underlying heart defect. We will evaluate propranolol, recently identified as a specific
SOX18 inhibitor, or Cmpd17, a novel small molecule collagen synthesis inhibitor we developed. These studies
will yield new mechanistic insights into the role of SOX18 signaling in developing pulmonary vascular disease
and highlight this TF as a druggable site for therapeutic intervention in children born with congenital heart
disease that results in increased PBF.

Public health relevance
PROJECT NARRATIVE The incidence of congenital heart defects in the U.S. is ~1 per 100 live births, and approximately 50% of these children require medical and/or surgical attention. Although survival for these children has improved, they continue to suffer significant morbidity and late mortality, in part because of abnormal vascular reactivity within their lungs. Our studies are designed to increase our understanding of the role of SOX18-mediated metabolic reprogramming in this process and could lead to improved therapeutic options for these infants and children.